Chemical Synthesis Core C

Core C Chemical Synthesis
Core Leader: Adriaan Minnaard
ABSTRACT
The Chemical Synthesis Core C supports chemical discovery and benchmarking experiments in ways that
cannot be achieved by analysis natural bacterial products. Whereas natural compounds from pathogenic
mycobacteria are generally limited to microgram yields, chemical synthesis can provide many milligrams to
durably supply large-scale experiments. Whereas natural products typically show many nearly co-eluting
molecular variants, synthesis can produce a single pure compound for benchmarking natural compounds and
as a standard for rigorously confirming newly discovered chemical structures. Synthesis of analogs with
defined chemical variations supports determination of structure-activity relationships. Core C is housed at the
Stratingh Institute at the University of Groningen, a world leading center for synthetic chemistry in a laboratory
that specializes in enantiospecific catalytic methods of chemical synthesis. Thus, Core C has a unique
expertise in production of bacterial metabolites with multiple chiral centers that define complex branched chain
structures, such as phthiocerol dimycocerosate, sulfoglycolipids, mycolic acid, phenolic glycolipid and other
lipids. Core C will produce milligram quantities of mycobacterial metabolites to support Projects 1 and 3. In
addition, the Core will provide both existing and new compounds to generate a comprehensive set of
standards for benchmarking mycobacterial lipids in the Profiling and Mapping Core B.